Training in Sleep, Circadian, and Respiratory Neurobiology

ABSTRACT
In its most recent research plan, the NHLBI’s National Center for Sleep Disorders Research
identified the need to train investigators as its highest priority. The Harvard Medical School
Division of Sleep Medicine Program for Training in Sleep, Circadian and Respiratory
Neurobiology, based at the Brigham and Women’s Hospital, has been addressing this need since
1998 and has been modified to address the new challenges in our field. This program provides
structured, comprehensive research training to prepare outstanding individuals for academic
positions in the broad field of sleep science and sleep medicine. For each trainee, the training
program consists of core required courses and activities, elective courses and activities, and an
intensive research experience. Cross-disciplinary and translational research is a highlight of this
program, and formal mentoring and tracking components are integral features. Intensive research
training experiences are available across the breadth of sleep, circadian and respiratory
neurobiology areas, including basic as well as clinical and translational research opportunities,
with several program projects that span multiple laboratories and institutions. There are 15 Full
Preceptors with extensive experience and demonstrated success at training predoctoral and post-
doctoral fellows, well-funded research programs (training faculty have current research support
totaling over $25 million of direct costs per year), and outstanding resources that trainees will
utilize for research. In addition, we have 11 Associate Preceptors who also oversee our trainees,
and are actively being trained to be our next generation of mentors. Our training record over the
past decade reveals the success of our efforts to train leaders in academic sleep science. Of our
pre- and post-doctoral trainees funded by this training grant over the last 10 years, >80% have
remained in academic medicine (still in academic training or now in faculty positions). More than
40% of those still in academic medicine have already received external grant support as PI or Co-
I with the remainder well on their way to independence. We propose to utilize this network upon
networks to deliver an outstanding focused training program. Funds are requested for the
implementation of an intensive training program on behavioral and social determinants of sleep
and circadian health and their relationship to sleep health disparities, and to make this expanded
curriculum widely available to all interested in the sleep, circadian, social science, and other
research communities. This will be accomplished through the addition of biweekly lectures to our
T32 curriculum as well an intensive 2-day in-person training program on our campus. Enduring
training materials will be available in professional quality for widespread public access.

Public health relevance
PROJECT NARRATIVE Sleep and circadian rhythm disorders disproportionately disrupt the lives of members of racial/ethnic groups that have faced historic and systemic marginalization. Our NHLBI supported Training Program in Sleep, Circadian and Respiratory Neurobiology is focused on training a new generation of investigators. We propose to add an intensive training program on behavioral and social determinants of sleep and circadian health to ensure that our trainees will be equipped to tackle critical questions that will ultimately improve the lives of all patients, including health disparities populations, who are suffering from sleep and circadian disorders.